RECK regulation of NASH and fibrosis

PROJECT SUMMARY/ABSTRACT
Nonalcoholic fatty liver disease (NAFLD) is a global epidemic, progresses to nonalcoholic steatohepatitis (NASH)
and fibrosis, and results in the development of hepatocellular carcinoma and increased cardiovascular mortality.
Unfortunately, no pharmacological therapies are available yet to treat NASH and fibrosis, necessitating the
identification of novel targets and approaches. RECK (Reversion Inducing Cysteine Rich Protein with Kazal
Motifs), a unique membrane-anchored protein, has been shown to inhibit multiple mediators involved in
inflammation and fibrosis. Our novel preliminary data demonstrate that hepatic RECK protein levels are markedly
reduced with increasing severity of NASH and fibrosis in clinical patients and in our pre-clinical mouse model of
western diet (WD)-induced NASH and fibrosis. Since RECK gene deletion is embryonically lethal, we generated
RECK floxed (RECKfl/fl) and CAG-CATflox-RECK transgenic mice. Our proof-of-concept pilot studies demonstrate
that while hepatocyte-specific RECK knockdown by AAV8-mediated Cre recombinase exacerbates NASH and
fibrosis in short-term WD-fed mice, its overexpression in hepatocytes blunts liver inflammation, Kupffer cells (KC)
and hepatic stellate cell (HSC) activation. Moreover, our preliminary in vitro data in primary mouse hepatocytes,
KCs and HSCs in which RECK is either silenced or overexpressed support our in vivo studies. These preliminary
studies suggest that sustaining RECK expression is hepatoprotective. Therefore, we hypothesize that Cre-Lox
mediated RECK deletion specifically in hepatocytes enhances pro-inflammatory signaling by enhancing
amphiregulin (AREG) cleavage by ADAM (A Disintegrin And Metalloproteinase domain-containing protein) 10-
and 17, leading to increased epidermal growth factor receptor (EGFR) and HSC activation collectively
contributing to worsening of long-term WD-induced NASH and fibrosis (Aim 1). Conversely, transgenic
overexpression of RECK, specifically in hepatocytes, will be protective. We will also determine if rescuing RECK
expression by ectopic overexpression in hepatocyte-specific RECK deficient mice with established WD-induced
NASH and fibrosis can be reversed (Aim 1). Since KCs are the predominant resident liver macrophages and
HSCs are considered the principal cell type responsible for hepatic fibrosis, we will establish the importance of
RECK deletion and transgenic overexpression in Kupffer cells and HSCs on cellular injury and activation,
extracellular matrix deposition, and fibrosis (Aim 2). In both Aims, molecular mechanisms underlying
inflammation and fibrosis will be investigated in co-culture studies using primary hepatocytes, KCs and HSCs
isolated from these gene-altered mouse models. Thus, our proposed genetic and interventional approaches will
mechanistically establish RECK as a novel upstream regulator in the pathogenesis of both NASH and fibrosis
with potential as a future therapeutic.

Public health relevance
PROJECT NARRATIVE Nonalcoholic fatty liver disease (NAFLD) has become a global epidemic with its progression to nonalcoholic steatohepatitis (NASH; hepatic inflammation) and fibrosis resulting in increased cardiovascular disease mortality and the development of hepatocellular carcinoma. A poor understanding of the underlying causes of NASH and fibrosis has severely limited the development of effective therapeutic and preventative strategies. The project will examine the novel relationship between hepatocyte, Kupffer cell and hepatic stellate cell RECK (Reversion Inducing Cysteine Rich Protein with Kazal Motifs) and the regulation of NASH and fibrosis with outcomes that will improve our understanding of the mechanisms responsible for NASH and highlight potential therapeutic targets for the future treatment of the disease.